Early life adversity amplifies behavioral opportunism by altering striatal dopamine signaling

PROJECT SUMMARY
Early life adversity (ELA) is associated with a significant increase in risk for substance use disorder. However, the
mechanisms by which ELA increases the risk for substance use disorder are not well understood. Here, I will test hypotheses
about how ELA shapes motivation for reward as a function of reward availability by altering the striatal dopamine system
in a mouse model. In preliminary data, I demonstrate ELA increases “behavioral opportunism”, exerting more effort on
immediately available and more probable rewards, and less effort on more distant, less probable rewards, compared to
controls. I hypothesize the ELA amplifies behavioral opportunism by altering both relatively static receptor expression and
dynamic striatal dopamine signaling. In Aim 1, I will test the hypothesis that ELA-induced alterations in dopamine receptor
D1 expression (traditionally associated with reward/benefit sensitivity) and D2 expression (traditionally associated with
effort/cost sensitivity) are sufficient to alter cost-benefit trade off calculations to produce behavioral opportunism.
Specifically, I will leverage a biologically informed computational model of behavior to assess the impact of striatal
dopamine signaling on cost-benefit calculations. Next, I will test whether the model generalizes and can predict behavioral
opportunism in a probabilistic bandit task, altering between rich and poor reward environments. Independent of relatively
stagnant alterations in the dopamine receptors (Aim 1), I hypothesize that ELA steepens the dopamine ramp to dynamically
produce behavioral opportunism (Aim 2). In Aim 2, I will build a dynamic model of an animal’s instantaneous perception
of state value (how rewarding the environment is at a particular moment) to make predictions about behavior in discrete,
within-trial behaviors (e.g. trial initiation, and reward retrieval). This model will be designed to recapitulate my preliminary
data showing that ELA animals exhibit delays to initiate “harder” trials, but then exhibit steeper increases in speed when
reward is near or readily available. Based on prior work showing that dopamine tone tracks state value, I will use in vivo
fiber photometry to measure real time dopamine release to test the hypothesis that striatal dopamine produces dynamic
behavioral opportunism by encoding more dynamic changes in state value.
Through the Research and Training Plan, the I will deepen my theoretical and conceptual knowledge of behavioral,
cognitive and neural mechanisms underlying learning and behavior, while acquiring advanced systems neuroscience and
quantitative techniques, including in-vivo fiber photometry, computational modeling and sophisticated behavioral analysis.
The training acquired through this grant will allow the applicant to use an interdisciplinary approach when addressing how
early life experience shapes motivation and decision-making. Overall, the proposed work will inform a rich literature
regarding the mechanisms by which early life experiences lead to alterations in motivation and striatal dopamine. This work
will provide insight into ELA vulnerabilities that could help explain why early life trauma increases the propensity for
substance use disorder.

Public health relevance
PROJECT NARRATIVE Early life adversity (ELA) is associated with increased risk for substance use disorder, but disturbances in reward-related mechanisms underlying vulnerability to substance use disorder are unknown. This project will leverage a mouse model to understand how ELA increases motivation for accessible rewards but decreases motivation for less accessible rewards (termed behavioral opportunism). This project will take an interdisciplinary approach using behavioral analysis, in vivo dopamine tone measurements and computational modeling to elucidate how ELA alters static and dynamic dopaminergic processes underlying behavioral opportunism.